Mechanisms underlying the formation and function of the sweat gland dermal niche

PROJECT SUMMARY
Humans rely on sweating to remove excess heat from the body, making the eccrine sweat gland an
indispensable component of the human thermoregulatory system and an organ essential for human survival.
During development, epidermal progenitors within the eccrine placode differentiate into multiple specialized cell
types that are ultimately partitioned into specialized, functional compartments. A lack of understanding of how
the progressive differentiation of the eccrine anlage occurs has stalled efforts to regenerate these critical skin
appendages for the repair of traumatic skin injuries, leaving affected patients with potentially life-threatening
deficits in thermoregulation. We have recently identified a novel eccrine dermal population, the Engrailed 1-
dependent eccrine niche (EDEN), that is required for eccrine gland formation in mice, and gives rise to a distinct
dermal lineage that is persistently associated with each developing human and mouse eccrine gland. A first-of-
its kind dermal niche to be described for eccrine glands, understanding how EDEN arises and is maintained, and
what factors EDEN produces to instruct eccrine development are entirely unknown. Accordingly, the goals of
this proposal are to define the cellular mediators required for EDEN induction, differentiation, and maintenance
(Aim 1) and to identify EDEN-produced effectors required for eccrine differentiation (Aim 2). Our research
strategy employs: a) functional experiments in mice using existing alleles to carry out targeted genetic
perturbations of EDEN and the associated eccrine epidermal anlage and also b) candidate-based and systematic
discovery of EDEN molecular effectors required for eccrine differentiation using genetically-targeted, single cell
transcriptomics followed by high-throughput seqFISH+ based validation in both human and mouse eccrine-
forming skin, and functional testing in vivo using genetic disruption in mice. Our findings will define the regulators,
functional properties, and effectors of the eccrine niche to reveal the extrinsic drivers of eccrine developmental
progression. Made possible by the unique biological and technical expertise of our team, this first-of-its kind,
instructive recipe for eccrine formation will seed translational efforts to regenerate these essential appendages
and identify novel genetic targets for alleviating eccrine disorders.

Public health relevance
PROJECT NARRATIVE Eccrine sweat glands are water-secreting exocrine organs that arise from the skin during development and are indispensable components of the human thermoregulatory system. We have identified a novel population of cells in the dermal skin layer that is specified immediately next to each developing human and mouse eccrine gland and have shown that eccrine glands fail to develop when this dermal population is ablated. The proposed aims will define the mechanisms through which this eccrine-associated dermal population forms and directs eccrine gland formation, thereby generating a first-of-its kind recipe of extrinsic factors that can be leveraged in therapeutic efforts to repair and regenerate these essential human skin appendages.